Mapping and controlling gene expression in inhibitory interneurons mammals

Project Summary: Fundamental to furthering our understanding of the brain is the ability to longitudinally track changes in gene expression over time in different contexts (e.g. development or learning) (Aim 1) and to develop methods to target and manipulate specific neuronal cell types regardless of species (Aim 2). This proposal is aimed at achieving these goals in both genetically amenable and non-­amenable species. While we anticipate that the methodologies we will develop will be broadly useful in a multitude of contexts, we will leverage our experience and knowledge of the specification and development of interneurons as a means to validate our approaches. Forebrain interneurons are a particularly robust context to develop these methods because the circuits interneurons contribute to during development are both dynamic and transient. This makes them a particularly attractive target for exploring longitudinal gene expression (Aim 1). This will be achieved using a modification of the DamID method, which we have redesigned to make inducible at particular developmental timepoints. Moreover, the diversity within this population is considerable, making them an ideal target for exploring methods to efficiently target subpopulations without the need for transgenic tools (Aim 2). In this aim we will leverage transcriptome data sets, including data produced in Aim1. Utilizing a computational program identify enhancer elements for mediating directed gene expression in rAAVs. Viruses produced in this aim will be validated for use in mice and less genetically amenable species, including non-­human primates.

Public health relevance
Project Narrative Interneuron dysfunction has been linked to several major neurological diseases such as epilepsy, schizophrenia and autism, with emerging evidence indicating that defects of specific interneuron subgroups during development may play a role in the etiologies of these diseases. One potential therapeutic avenue is to develop novel strategies to modulate the function of specific interneuron subgroups. The experiments outlined in this proposal will utilize innovative strategies to characterize genes expressed by specific interneuron subgroups, and harness this knowledge to develop a series of viruses for manipulating activity in distinct interneuron populations.